PILOT STUDY ON EFFECT OF A FRUIT AND VEGETABLE INTERVENTION ON OXIDATIVE DAMAGE

1. To test if participants can be recruited to consume, and adhere to, controlled diets containing varying amounts of fruit and vegetables containing dietary antioxidants for a five-week period. 2. To investigate analytic and measurement properties of markers of oxidative damage in order to plan a larger-scale intervention. 3. To obtain preliminary evidence of any effect of a fruit and vegetable intervention on markers of oxidative damage related to carcinogenesis and atherogenesis.